Cell-drones: engineered stem cell nanovesicles as alternatives to exosomes

PROJECT SUMMARY
Studies have demonstrated that adult stem cells such as mesenchymal stem cells (MSCs) repair
myocardial infarction (MI) or ischemia/reperfusion (I/R) injury by indirect paracrine mechanisms rather than by
differentiation and tissue replacement. In the past decade, extracellular vesicles (EVs) have emerged as
promising cell-free agents for treating ischemic injury. Several exosome-based therapeutic companies have
launched early phase clinical trials. However, the large-scale production of EVs remains a challenge. We seek
to develop a scale-up friendly method to generate a large number of therapeutic nanovesicles (NVs) from
MSCs by extrusion. Passing through a series of extrusion microfilters, the MSCs can be converted into billions
of NVs. Those engineered cell vesicles serve as “cell-drones” to deliver biological information to the recipient
cells. Companies such as MDImune and SQZ Biotech are conducting clinical trials using extruded
nanovesicles in the area of oncology and infectious diseases. We wonder whether those cell-drones would
carry the regenerative materials from MSCs and can promote tissue repair in a way similar or superior to
naturally secreted EVs. In this proposed study, we plan to investigate the fabrication, characterization and
toxicity of NVs (Preliminary study). After that, we will test the therapeutic effect of NVs on a mouse model (AIM
1) and a porcine model (AIM 2) with cardiac I/R injury. Then, we will elucidate the mechanisms underlying the
therapeutic benefits of MSC NVs and create “super” NVs with enhancement cargos (AIM 3). This leads to our
central hypothesis that extrusion is a highly efficient method to generate a large quantity of therapeutic NVs
that can potentially be manipulated, and may replace EVs in regenerative medicine applications.

Public health relevance
PROJECT NARRATIVE Extracellular vesicle (EV) therapy is a promising strategy for tissue regeneration. But the large-scale production of EVs remains a challenge. In the proposed study, we seek to develop a scale-up friendly method to generate a large number of therapeutic nanovesicles (NV) from MSCs by extrusion.